PAH ADDUCT ORIENTATION IN DNA

Polycyclic aromatic hydrocarbons (PAH) are classic carcinogens that are environmentally ubiquitous. Metabolic activation produces the ultimate carcinogenic species, the bay-region diol epoxides. Within the set of four optically isomeric diol epoxides that may be formed from a parent PAH, however, widely different carcinogenicities may be observed. There are stereospecific preferences for what kinds of adducts are formed in the target, DNA, by a given isomer, and what kinds of biological responses result. This project will investigate the orientation of PAH diol epoxide adducts within the adducted DNA strand, to demonstrate if as preliminary evidence suggests, orientation is determined by the choice of cis or trans addition of the diol epoxide to DNA plus the R or S configuration of the attacking epoxide carbon. These data will permit a comparison between the carcinogenicity of the diol epoxide isomers and the amount of 5' or 3' oriented adducts they form. In addition to orientation, the project will determine any disruptive effects the adducts have on DNA structure. The effect that adjacent thymine methyl groups have on dA adduct orientation will be determined by the relative resistance to digestion by 3' and 5' exonucleases of cis and trans dA adducts formed on DNA oligomers containing 5' , 3' and no adjacent T. Large quantities of CTTCCACCTCC containing a cis or trans diol epoxide adduct at the single dA will be synthesized and purified. 1-D and 2-D NMR methods will be used to indicate adduct orientation by showing overlap between the adduct and the bases 5' or 3' to it, both in the single stranded oligomer and in duplexes. Footprinting will confirm the orientation. Lowering of duplex oligomer melting temperatures will indicate disruption of the helical structure. The 2-D NMR analysis will also reveal any disruption and mispair possibilities. These types of analyses will be done with dG adducts as well.